Predictors of Recidivism to Obesity in Weight-Reduced Individuals

Obesity is a major contributor to human illness and health care costs by virtue of its functional associations with
type 2 diabetes, hypertension, fatty liver, dyslipidemias, various cancers, degenerative brain disease and, very
recently, contribution to morbidity and mortality associated with SARS-CoV-2 infection. Modest weight loss can
mitigate the severity – or entirely reverse - many of these phenotypes. Maintenance of a 10% reduced body in
obese or lean individuals invokes homeostatic changes in energy expenditure (decreased) and hunger
(increased) that tend to restore body weight. These changes are conveyed by persistent complex molecular-
physiological processes in the brain and autonomic nervous systems, thyroid and leptin axes, skeletal muscle,
and adipose tissue. Individuals differ in the intensity of these responses, perhaps accounting for differences in
long-term success for weight loss maintenance. This study prospectively examines the behavioral and molecular
physiology of these systems following a lifestyle-mediated 10% weight reduction in individuals with overweight
or obesity, and examines the contributions of these factors to amount of weight regain in the one year period
following achievement of the weight reduction during a period of minimum clinical intervention. Our Specific
Experimental Aims are to:
1. Examine the behavioral, metabolic, and environmental impacts on success in sustaining 10% weight loss
by measuring the association of (a) ad lib energy intake (EI), (b) 24h energy expenditure (EE); and (c) the
individual’s food environment at reduced body weight on changes in body weight and fat mass one year
following achievement of 10% weight reduction.
2. Assess the physiology of the weight-reduced state in dynamic circumstances in order to provide predictors
of weight outcome at 12 months after 10% weight loss. EI and EE will be measured: (a) in response to a
single dose of leptin administered after achievement of reduced body weight; (b) 6 months following weight
loss.
3. Generate mechanistically-informed regression equations predicting change in body weight in the 12
months following 10% weight loss. “Endophenotypes” related to EI and EE will be measured in the weight-
reduced state: food-choice task performance associated with food intake and fMRI activity in the dorsal
striatum; sleep/circadian rhythms; skeletal muscle contractile efficiency (in vivo and ex vivo), plasma
metabolomics /exposomics and endocrines, urinary catecholamines, gene expression and epigenetics of
adipose tissue and muscle, and peripheral blood mononuclear cells. These endophenotypes, EI and EE,
will be used to generate predictive equations that will quantify the relative contributions of these factors and
suggest possible interventions to assist in long-term maintenance of reduced body weight.

Public health relevance
Sustained weight loss of 10% reduces the severity of many of the medical problems associated with obesity such as diabetes, heart disease, high blood pressure and fatty liver. However, weight loss causes changes in energy metabolism and hunger that cause many people to regain lost weight. This study is designed to identify the physiological and molecular bases for these changes in persons with overweight/obesity by detailed prospective analyses of metabolism and food intake in a one year period following 10% weight loss.